Targeted vaccines against pulmonary NTM infections in vulnerable populations

NTM infections have now surpassed tuberculosis in the U.S. and are a global concern. Long (>12 months)
treatment regimens and severe toxic side effects of drug treatment warrant urgent development of new
strategies. We hypothesize that a vaccine targeted against pathogenic NTM will improve immunity in at-
risk individuals, prevent NTM-lung disease (NTM-LD), and improve therapeutic clinical outcomes when
used as an adjunct to drug treatment. We propose the development of two innovative NTM-LD vaccine
candidates: an adjuvated subunit vaccine and a novel replicon RNA-based vaccine. The 13 vaccine candidate
antigens, which have known importance in Mycobacterium avium (MAV) and Mycobacteroides abscessus (MAB)
infections, will undergo a thorough search for homology to >1,700 clinical NTM isolates. The 3 adjuvants that will
be tested are similar to those that have undergone human clinical vetting, including AS01E, GLA-SE, and CAF01.
Subunit vaccine candidates will be screened using an innovative NTM mycobacterial growth inhibition assay (N-
MGIA). The top 4 antigen candidates that provide the greatest reduction in bacteria in the N-MGIA will be
included as a ‘combo’ and mixedwith the 3 clinically relevant adjuvants. RNA-based replicon vaccines, designed
to express the 4 antigens, will be combined similar to the subunit vaccine, for further in vivo efficacy studies.
We have a scientifically rigorous plan to evaluate efficacy of the NTM vaccine candidates in mouse models
incorporating (i) parenteral and mucosal routes of immunization, (ii) vaccine durability (6 months), (iii) efficacy
evaluation using two different clinical NTM isolates (MAV and MAB), (iv) use of BCG as a control vaccine, and
(iv) C57BL/6, Beige, and C3HeB/FeJ (Kramnik) mouse models for vaccine efficacy testing (reduction in bacteria
and lung pathology). Rigor of prior research is included in 2 published papers showing efficacy with BCG and a
prototype subunit vaccine against a clinical isolate of MAV. In this work, the aerosol route of infection leads to
lung disease in Beige mice. We are also utilizing the published MAB model in C3HeB/FeJ mice, where infection
with a clinical MAB isolate is achieved through intravenous (i.v.) injection. Both male and female mice will be
included to determine whether ‘sex as a biological variable’ mimics that seen in women, where incidence and
prevalence of NTM-LD is greater than that observed in men. Animal numbers for our experiments are powered
for efficacy based on prior statistical power calculations and past NTM challenge experiments. Our vaccine
candidates will be evaluated in high-risk target population mouse models, including (i) use of anti-TNF
strategies, (ii) aged populations, and (iii) chronic obstructive pulmonary disease (COPD). Vaccine efficacy will
also be tested as an adjunct to drug treatment (Amikacin) in a MAV therapy model. This work, through an
extension of our prior R21 and based on a systematic approach towards vaccine development, will allow delivery
of an NTM-LD vaccine. We have previously developed M72/AS01E and ID93+GLA-SE, both in Phase 2 clinical
trials. Funding this R01 project to develop an NTM-LD vaccine will address this global infectious disease threat.

Public health relevance
This project aims to develop a highly effective vaccine for prophylactic and therapeutic use in individuals at risk of acquiring lung disease due to nontuberculous mycobacteria (NTM). A vaccine that leads to increased immunity against pathogenic NTM could improve patient outcomes in high-risk individuals, including the elderly, those with chronic obstructive pulmonary disease, or in people that require the use of anti-inflammatory agents such as anti-TNF therapy. A therapeutic application of a vaccine against NTM-lung disease, used as an adjunct to drug treatment, would circumvent the need for lengthy drug treatments with agents that have known harmful side effects.